Assessing TRUE HAVEN Housing Intervention Impact on Parent Experiences and Youth Mental Health

PROJECT SUMMARY
In the United States, over 5 million children have experienced the incarceration of a parent—a consequence of
five decades of mass incarceration, which is a manifestation of structural racism. Policies and practices driving
mass incarceration children who are Black have a seven times higher likelihood of experiencing parental
incarceration than their white peers. Parental incarceration is associated with worse child mental health,
including internalizing (e.g. depression, suicidal ideation) and externalizing (e.g. aggression, substance use)
behaviors, and it contributes to disparities in child mental health. Housing insecurity is one form of economic
hardship disproportionately experienced by families who have been impacted by incarceration. Housing
insecurity is associated with more child and adolescent mental health problems including internalizing and
externalizing symptoms, particularly for families impacted by the criminal legal system. The overall research
goal of this supplement is to build evidence on how structural interventions, specifically an intervention to
improve housing stability, affects child mental health among those whose parents have been incarcerated. We
will build upon the infrastructure of the TRUsted rEsidents and Housing Assistance to decrease Violence
Exposure in New Haven (TRUE HAVEN) grant, a multi-level intervention focused on housing stability and
mental well-being, to describe and explore potential changes in youth mental health among TRUE HAVEN
housing intervention participants. Specifically, we will embed a qualitative study and a cohort feasibility study of
youth and their parents within the ongoing hybrid type 1 effectiveness/implementation study of an intervention
that provides comprehensive financial education and financial support for housing in the form of rental
assistance, down payment assistance, and low-interest home loans among family members of incarcerated
people. The proposed aims are a logical extension of the parent project aims and add a novel exploration of
the impact of TRUE HAVEN on parent-child relationships and on youth mental health. Further, this supplement
will provide Dr. Destiny Tolliver with necessary skills to build an independent research career.

Public health relevance
PROJECT NARRATIVE This diversity supplement aims to build evidence on how an intervention to improve housing stability affects child mental health among those whose parents have been incarcerated. We will embed a qualitative study and a cohort study to explore the mental health of youth and their parents within an ongoing hybrid type 1 effectiveness/implementation study of an intervention that provides comprehensive financial education and financial support for housing in the form of rental assistance, down payment assistance, and low-interest home loans among family members of incarcerated people. This supplement will provide Dr. Destiny Tolliver with necessary skills to build an independent research career in the field of child mental health equity.